The role of U1 snRNP proteins in snRNP biogenesis and gene expression regulation

PROJECT SUMMARY
The long-term goal of this proposal is to understand the regulatory mechanisms of U1 small nuclear
ribonucleoprotein (U1 snRNP) in snRNP biogenesis and its role in protein-coding gene regulation. U1 snRNP,
the most abundant RNP particle among the spliceosomal snRNP, plays a key role in excising introns (splicing)
and preventing premature termination of nascent transcripts (telescripting). Both activities are ensured by the
RNA:RNA base-pairing between U1 snRNA and 5’ splice site (5’ss). Pan-cancer patients possess multiple
mutations in the U1 snRNA, including 5’ss and U1 snRNP-specific protein binding sequences, which result in
alternative splicing of oncogenes and tumor suppressors through novel 5’ss recognition. However, our
preliminary data showed that those U1 snRNA mutations do not form a stable Sm core, a key intermediate
assembled by the SMN (survival of motor neuron) complex, which determines the stability and abundance of the
U1 snRNP in cells. Moreover, we identified that a U1 snRNP-specific U1C protein, previously known to stabilize
5’ss:U1 snRNA base-pairing, plays a critical role in regulating Sm core assembly of all snRNAs. The objective
of this proposal is to investigate the mechanism of the newly discovered role of U1C as a gatekeeper in snRNP
biogenesis, its potential contribution to the quality control of spliceosomes, and the regulatory mechanism in
splicing and telescripting activity. This project will simultaneously address both functions of U1C by harnessing
two established components to dissect the role of U1C in snRNP biogenesis as well as its involvement in intronic
polyadenylation and 3’UTR length changes, molecular characteristics of the oncogenes in cancer. We propose
to pursue three specific aims: 1) Elucidate the role of U1C with SMN complex as a gatekeeper in snRNP
biogenesis. 2) Investigate the effects of U1 snRNA mutations found in pan-cancer patients on Sm core assembly.
3) Examine the U1C interaction with mRNA 3’-end termination machinery in telescripting. Using biochemical
approaches, we will investigate the molecular connections between U1C-SMN complex and U1C-U1 snRNA.
By examining these connections, we can better understand how U1C controls the snRNP repertoire and
ultimately impact the function of spliceosome. Moreover, we will delineate the U1C’s interaction with mRNA 3’-
end processing machinery. This interaction is a key switch that can convert U1 snRNP from productive splicing
to premature mRNA termination or 3’UTR shortening through the loss of 5’ss binding. To elucidate the multi-
faceted regulation mechanism of U1C, we will employ in vitro Sm core assembly, RNA-affinity purification, in
vitro mRNA processing assays, and in-cell formaldehyde-crosslinking coupled with immunoprecipitation
methods. The expected outcome of this project will identify the role of U1C as a in snRNP biogenesis and mRNA
metabolism, thus explaining the consequence of the U1 snRNA mutations in pan-cancer and providing evidence
of gene regulation by the loss of telescripting activity.

Public health relevance
PROJECT NARRATIVE Maintaining the repertoire of small nuclear ribonucleoproteins (snRNP) is crucial for regulate messenger RNA metabolism, which determines the isoforms of nascent transcripts and produces a variety of protein isoforms necessary for the cellular function. Therefore, investigating the quality control mechanisms of snRNP at the molecular level is fundamental for understanding gene expression profiles in both normal and disease development. The proposed study aims to investigate the molecular function of snRNP-specific proteins as gatekeepers of snRNP biogenesis and as key switch controlling the protection of full-length nascent transcripts.